Improving Assessment for Neurocognitive Impairment among Perinatally HIV Infected Youth

South Africa (SA), a resource limited setting with the world’s largest population of people living with HIV, has
hundreds of thousands of perinatally HIV-infected (PHIV+) youth who are rapidly becoming adolescents. PHIV+
adolescents must contend with the negative effects of life-long viral infection and chronic inflammation on their
neurodevelopment, medical status, mental health, and, for many, the demands of lifelong ART adherence –
placing them at risk for not achieving these important milestones. Neurocognitive impairment (NCI) is chief among
these negative effects. NCI in PHIV+ adolescents most commonly affects the neurocognitive domains of working
memory, executive function and processing speed. NCI can affect youth’s ability to perform in and complete
school, interact successfully with peers and adults, find employment, initiate and maintain long-term relationships,
and function independently. NCI can also interfere with adherence to medication, which is critical in HIV, and
increase poor decision-making and greater HIV transmission risk behaviors (e.g., unprotected sex). PHIV+ youth
in SA are also at risk for NCI due to numerous psychosocial problems that are very common in resource limited
settings, such as poverty and poor education. The first step in addressing NCI in PHIV+ adolescents is detecting
and diagnosing it, but doing so in South Africa is seriously hampered. Few neurocognitive tests and screening
tests exist for the hundreds of thousands of PHIV+ youth in SA. The tests that do exist for PHIV+ youth in SA
require highly trained personnel to administer and score, take several hours to administer, lack ecological validity
to predict real-world outcomes, and many suffer from cultural biases because they were developed for and
normed on youth in the US or Europe. Given how overburdened the SA healthcare system is and its reliance on
task-shifting various components of care to lay health workers (LHWs), without accurate, clinically useful, and
relatively brief NC tests that can detect NCI and meet the demands of task-shifting in RLSs, PHIV+ adolescents
in SA will not be assessed, missing opportunities to detect NCI and intervene. NeuroScreen is a brief, easy-to-
use app for Android devices to assess and screen for NCI that is designed to be administered by a wide
range of non- expert healthcare personnel in clinical settings. The app contains nine neurocognitive tests
assessing processing speed, executive functions, working memory, verbal memory, and motor speed. It is
standardized and highly automated, requires minimal training to administer, and does not require record-
keeping or scoring. The proposed study will validate NeuroScreen for use with PHIV+ adolescents in SA by
(1) evaluating its internal validity, (2) sensitivity and specificity to detect NCI compared to a gold standard
neuropsychological test battery, and (3) characterize PHIV+ youth performance on it in the context of medical
and psychosocial factors. The study will also generate preliminary normative performance data among 13-17
year adolescents in SA. A neurocognitive assessment tool like NeuroScreen could be easily modified for use
in other disease populations and regions of the world that rely on task-shifting.

Public health relevance
Neurocognitive impairment has significant medical and behavioral consequences and is common among perinatally HIV-infected youth. In South Africa, where there are hundreds of thousands of perinatally HIV- infected youth, there are few neurocognitive tests available to detect neurocognitive impairment that are brief, computerized, available in isiXhosa (the predominant language of perinatally infected youth in the Western Cape region of South Africa, where the proposed study will take place), designed to be used by lay health workers, and use the interactivity of touchscreens available on tablet devices. Offering HIV providers and clinics with a self-contained, computerized neurocognitive testing tool that automates the neuropsychological testing needed to detect neurocognitive impairment using the computing power, touchscreen, network connectivity, and ultra-portability of mobile technologies can help make neurocognitive assessment acceptable and sustainable and help providers detect impairment earlier, communicate more effectively with patients about the impact of impairment and ways to minimize it, offer tailored health improvement and prevention interventions, make better referrals, and holds promise for improving both individual and public health.